Mechanisms of autoimmune disease risk in IL2/IL2RA-dependent immune tolerance

Project Summary
Interleukin-2 is a potent T cell growth factor with crucial roles in both immunity and self-tolerance. Genome-wide
association studies (GWAS) in humans have shown that genetic variation at the IL2 and IL2RA loci influence
susceptibility to multiple immune-mediated diseases including allergic asthma, systemic lupus erythematosus,
and inflammatory bowel disease (IBD), identifying this as a key molecular axis that controls immune activity.
However, mechanistic basis of disease risk for these polymorphisms is poorly understood. We have new
evidence that the cis-regulatory architectures of IL2 and IL2RA extend much further from the gene than
previously appreciated, encompassing regions harboring known disease-associated variants, and we
hypothesize that polymorphisms within these elements control the level and timing of IL-2 and IL-2RA expression
to control the balance of tolerance vs. inflammation. In this application, we propose a comprehensive screen for
potential cis-regulatory elements that interact with the IL2 and IL2RA genes using state-of-the-art epigenomic
approaches like ATAC-seq and Capture-C-seq. We will establish how these elements contribute to IL2 and
IL2RA gene expression using powerful, CRISPR/CAS9-based genome editing approaches. To study the impact
of disease-associated genetic variation at these regulatory elements on immune function in in vivo systems, we
will analyze the responses of genetically characterized subjects curated from the Benaroya Research Institute
biorepository, and create mice in which orthologous murine Il2 and Il2ra enhancer sequences have been
replaced with human risk alleles, assessing the disease susceptibility in models of allergic asthma, SLE and IBD.
Our studies will provide comprehensive maps of the transcriptional architecture of IL2 and IL2RA, insights into
the molecular basis for the genetic association of IL2 and IL2RA with autoimmune disease, and may guide the
design of new approaches for the treatment of organ transplant rejection and inflammatory disease.

Public health relevance
PROJECT NARRATIVE Interleukin-2 is an immune hormone that regulates immunity to infection, but also influences the development of inflammatory disorders. Human genetic variation at IL2 and its receptor IL2RA is associated with loss of self- tolerance and increased susceptibility to autoimmune disease. However, these polymorphisms are not in the genes themselves, but are located kilobases away in non-coding DNA. We hypothesize that the function disease- associated variants lie within key gene regulatory regions, and the studies proposed in this application will use state-of-the-art 3D epigenomics and CRISPR/Cas9 genome editing to solve the mystery of how non-coding variation influences IL-2-dependent immune functions, and may suggest new ways that tolerance can be restored, and inflammatory disorders can be treated or avoided.